Disparities in cardiovascular health in young adults with type 1 diabetes

PROJECT SUMMARY
Cardiovascular disease (CVD) is the leading cause of death for people with type 1 diabetes (T1D), and
abnormalities preceding overt CVD (left ventricular hypertrophy, diastolic dysfunction) are more prevalent in T1D
as early as childhood. Disparities in CVD and its risk factors within T1D according to the social construct of
race/ethnicity are concerning, especially given rising incidence of T1D specifically in non-Hispanic Black (NHB)
and Hispanic youth. Such youth are more likely to have elevated weight, blood pressure, lipids, and glycemia
than non-Hispanic White (NHW) youth from T1D diagnosis onward, and NHB individuals experience twice the
CVD mortality and 8 times the CVD event rate as NHW peers. Prior studies of CVD within T1D focused on NHW
participants with ≥25 years T1D duration treated in an earlier clinical environment, and therefore do not reflect
today’s increasingly diverse T1D population with ostensible access to modern diabetes technologies and
subspecialty care networks. We and others have reported that social determinants of health (SDOH), including
socio-economic factors (low income, limited parental education, food insecurity), inadequate health behaviors
(unhealthy diet, physical activity and sleep patterns, smoking), and healthcare access barriers (lack of, or limited,
health insurance, high out-of-pocket costs), are associated with lower quality of T1D care and worse T1D
outcomes. The impact of SDOH on CVD risk factors and subclinical abnormalities within diverse T1D populations
is not known, yet critical for informing multi-level CVD prevention strategies for T1D. We propose to investigate
whether SDOH-related barriers may account for racial/ethnic disparities in CVD risk factor trajectories from
diagnosis onward and subclinical abnormalities in early adulthood. We will enroll 1000 participants from the
SEARCH for Diabetes in Youth Study, including 300 Hispanic or NHB young adults. We will rigorously investigate
racial/ethnic differences in prevalence of subclinical CVD in early adulthood (mean age 25 years, T1D duration
16 years) via new assessments of structural and functional abnormalities of the heart and vascular system (with
echocardiography, carotid ultrasonography, vascular tonometry). Longitudinal modeling of CVD risk factor
trajectories (weight, lipids, blood pressure, A1c, albuminuria, autonomic function), SDOH factors (as defined by
Health People 2030) collected from diagnosis onward will enable us to understand how and which SDOH barriers
account for racial/ethnic differences in CVD outcomes within T1D. Our aims are 1) To quantify racial/ethnic
disparities in trajectories of CVD risk factors, and in subclinical cardiac and vascular outcomes during early
adulthood among SEARCH participants with youth-onset T1D.; 2) To understand which SDOH-related barriers
are associated with CVD risk factor trajectories and subclinical cardiac and vascular outcomes, using mixed
methods; and 3) To determine if specific SDOH-related domains (identified in Aim 2) explain racial/ethnic
inequities in CVD risk factors and subclinical cardiac and vascular outcomes.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease (CVD) is the leading cause of death in people with type 1 diabetes (T1D), and is largely preventable. CVD disproportionately affects Hispanic and non-Hispanic Black people with T1D, but little is know about the factors contributing to these disparities. Our study is uniquely positioned to advance scientific understanding of disparities in CVD risk early in the T1D disease course by leveraging the comprehensive, longitudinal data available from the racially/ethnically diverse SEARCH sample coupled with novel CVD assessments in young adulthood. With continued increase in T1D incidence, especially in Hispanic and NHB youth, the number of individuals living with this condition is projected to triple by 2050, forecasting a substantial rise in the societal burden of managing T1D and preventing its CVD comorbidities. This work has the potential to inform the design of multi-level interventions to prevent CVD in individuals at highest risk due to T1D.